Assessment of Efficacy and Toxicity of T3 for Medulloblastoma Treatment

PROJECT SUMMARY/ABSTRACT
Medulloblastoma (MB) is the most common malignant brain tumor in children. Despite conventional treatment
including surgery, chemotherapy and radiation, a significant proportion of MB patients still succumbs to this
disease. Moreover, almost all patients suffer long-term side effects of the aggressive treatment, such as hearing
loss and cognitive deficit. Improved strategies to treat MB are urgently needed.
Our recent studies have unveiled that T3, the active form of thyroid hormone, inhibits MB tumor growth by
inducing terminal differentiation of tumor cells in mice, without causing noticeable weight loss. These findings
suggest that T3, an FDA-approved drug for hypothyroidism, holds promise as a potential approach for MB
treatment. To translate our discoveries into clinical trials, we propose to delve deeper into the toxicity and
therapeutic efficacy of T3 in mice. Specifically, our research will focus on two specific aims:
1. Aim 1: Evaluate the toxicity, pharmacokinetic, and pharmacodynamic properties of T3 in tumor-bearing mice.
2. Aim 2: Examine the therapeutic efficacy of T3 in combination with cytotoxic drugs or irradiation.
Our studies aim to furnish the preclinical data necessary for designing clinical trials to assess T3 as a potential
treatment for MB in patients, paving the way to apply T3 as a novel therapeutic modality for MB.

Public health relevance
PROJECT NARRATIVE Urgent solutions are imperative for treating medulloblastoma, the most prevalent malignant brain tumor. Our preliminary investigations have unveiled the potential of thyroid hormone to stimulate the maturation of medulloblastoma cells, consequently impeding tumor growth. In our proposed research, we aim to assess the toxicity and therapeutic effectiveness of T3, the active form of thyroid hormone, which will pave the way to use T3 for medulloblastoma treatment in clinical settings.